A Novel Non-Drug, Non-Surgical Hydrogel-Based Treatment of Glaucoma

PROJECT SUMMARY
Glaucoma is the leading cause of irreversible blindness worldwide. This optic neuropathy is often
associated with increased intraocular pressure (IOP), and all current treatments seek to reduce IOP to prevent
further vision loss. The current first-line treatment is the use of daily topical eye drop medications, which are
notably associated with low adherence rates and systemic side effects. Patients may go on to require surgery,
with potential for revisions and complications. Thus, improved technologies for IOP control are a pressing unmet
need. We previously demonstrated that expansion of the suprachoroidal space (SCS) of the eye using a hydrogel
injected via a microneedle (MN) reduces IOP for up to 4 months in rabbits, likely due to increased aqueous
humor outflow through the unconventional drainage pathway.
In this project, our long-term goal is to develop hydrogel-based SCS expansion as a novel glaucoma
treatment complementary to topical eyedrops and surgery. As a non-drug, non-surgical method, we expect that
this treatment approach can greatly improve patient adherence and treatment outcomes as compared to existing
approaches. The objectives of this proposal are to: (i) more definitively elucidate the mechanism of IOP
reduction due to SCS expansion; (ii) develop a hydrogel formulation that provides IOP reduction for at least 6
months after a single treatment, which will offer significant translational potential; and (iii) further investigate the
safety and efficacy of this treatment method. To achieve Aim 1, we will measure changes to aqueous humor
outflow through the conventional and unconventional pathways following hydrogel injections. Factors that may
affect hydrogel degradation, such as ciliary muscle contraction, will also be evaluated using a pharmacologic
agent that modifies ciliary muscle action in conjunction with hydrogel injection. In Aim 2, a slowly degrading
enzyme-digestible hydrogel will be developed to provide a longer duration of IOP reduction that can be
controlled/reversed by a healthcare provider. Aim 3 will assess the safety and efficacy of this treatment method
and the feasibility of repeat injections. The outcome of this work will be a novel glaucoma treatment method for
long-term IOP reduction, including evaluations in animal models, that will pave the way for future clinical trials.
My training plan provides excellent mentorship under my PhD thesis advisors, Drs. Ross Ethier and Mark
Prausnitz, whose expertise in glaucoma and drug delivery methods, respectively, will equip me with a strong
foundation in translational vision research and advance my professional development. My collaborators will also
provide guidance, such as for evaluating aqueous humor outflow in Aim 1 and hydrogel fabrication in Aim 2. I
have planned for longitudinal clinical experiences during my PhD that will prepare me for the last year of my
medical school and for residency training. I have intentionally chosen my thesis to align with my clinical interests,
and this training fellowship will be invaluable preparation for my career as a scientist and clinician in this field.

Public health relevance
PROJECT NARRATIVE Glaucoma is one of the leading causes of irreversible blindness worldwide, and current pharmacologic and surgical treatment methods have low adherence rates and associated complications. The suprachoroidal space can be expanded via a simple microneedle injection of a hydrogel and has been shown to reduce intraocular pressure. In this proposal, I will determine the mechanism of intraocular pressure reduction from suprachoroidal expansion, develop an optimal hydrogel for this application, and evaluate the safety and efficacy of this approach, which will lead to the development of a novel glaucoma treatment method without the use of pharmacologic agents or surgical procedures.